TR&D3: Standards and Tools for Simulator Composition and Credibility portal

TECHNOLOGY RESEARCH & DEVELOPMENT 3: PROJECT SUMMARY
Dynamic models are abstract specifications of systems, which simulators implement with
algorithms that update the systems’ state over time. Traditionally, biomedical simulations have
relied on models that utilize a single class of algorithm for the simulations’ duration. Specific
biological subsystems might be better suited for one method or another, and this has allowed
computational biologists to focus on those subsystems within the silos of fixed simulation
frameworks. To break these silos and address the challenges to reproducibility we developed the
BioSimulations platform, where simulators that implement a wide range of algorithms have
been containerized with a standard API into a quality controlled registry, and can be used for
reproducible online execution of models and sharing of results.
However, biology is multi-modal and multi-scale, with many heterogeneous processes operating
simultaneously and driving each other's dynamics. Because of this, biological simulations
increasingly require simulators that use multiple algorithms to handle different dynamic
processes. This approach is called hybrid simulation, integrative simulation, or co-simulation. It
has been used for multi-scale modeling, including whole-cell modeling, multi-cell modeling,
tissue models, and other complex biological models. While powerful, they have been primarily
developed ad hoc, are difficult to reproduce or expand upon, and are often hard-coded in
individual simulation platforms with a fixed set of pre-set algorithms.
The next step is to build on the foundation of BioSimulations with flexible and reproducible
definitions of composite simulations, which can be assembled through the use of software tools,
easily executed, and shared with others in the biomodeling community. We will expand
BioSimulations with an online portal for model composition, and add new tools for credibility
evaluation (with TR&D1) and model annotation (with TR&D2). This will allow users to more
easily build composite simulations of their own using reusable simulator modules, with tools
that let them inspect model elements, plug in new modules, execute compositions as multi-
algorithmic simulations, and evaluate their reproducibility and credibility. Driven by our
collaborative projects, we will exercise this new set of standards and tools with a series of
generic templates for several commonly-needed hybrid simulations and multi-cell simulation
methods. Users will be able to take these templates, load their own models and swap simulator
components as a way to iterate on model design and build upon prior work.